24th - 26th Annual Health Economics Conferences

DESCRIPTION (provided by applicant): The Health Economics Program in the Department of Health Policy and Management at the Boston University School of Public Health seeks funding to support continuation of the highly successful Annual Health Economics Conferences (AHEC) for 2013 (at the University of Pennsylvania), 2014 (at Rice University) and 2015 (at the University of Georgia). The AHEC conference uses a small conference format for rigorous presentation and discussion of health economics research, with special attention to its application to policy. In this context, the aims of these conferences are: (1) to advance the polic applicability of health economics by exploring theoretical issues with high potential for application to real-world health settings; (2) to improve the policy relevance of empirical health economics by fostering research that emphasizes the study of important current policy questions using rigorous methods; and (3) to develop the next generation of health economic scholars by placing promising junior economists with high-profile senior economists in an intensive 1.5-day, small group setting. Over the past 23 years, AHEC has been hosted by most of the major universities that offer advanced degree programs and have major funded research programs in health economics. The unique nature of each conference focus combined with the prestige of each university has ensured exceptionally high quality papers and serious interactions among conference participants. For these three years, the conference will build upon past success by (1) retaining the core structure and tradition of AHEC, with extensive discussion of leading-edge, policy-relevant research in health economics and (2) addressing the current changing health care reform environment by including sessions that focus on two critical issues in the cost, productivity, organization, and market forces of health care that are of curren importance for public policy and AHRQ.

Public health relevance
PUBLIC HEALTH RELEVANCE: The Annual Health Economics Conference brings together the leaders in the field of Health Economics to discuss and to present on issues that have a direct effect on public health policy in the US. The 24th, 25th, and 26th Annual Health Economics conferences hope to build upon the rich tradition established by the preceding twenty-three Annual Health Economics Conferences.